ADMINISTRATION OF IDEC-C2B8 WITH INTERFERON ALPHA IN PATIENTS WITH LYMPHOMA

This is a study of the safety and toxicity of IDEC-C2B8, a chimeric anti- CD20 antibody, in patients with relapsed B cell lymphoma during concurrent treatment with interferon alpha.